Comprehensive Ctr of Excellence in Disparities Res & Commun Engagement (CEDREC)

DESCRIPTION (As provided by applicant): The purpose of the Administrative Core is to integrate the components and scientific activities of CEDREC to ensure that the goals of all research, training, and community outreach initiatives are met. The Administrative Core will be directed by Dr. Boutin-Foster and co-directed by Dr. Mary Charlson. They will work with the directors and co-directors of all other cores to ensure that each operates at maximum efficiency and that they have the necessary resources to achieve their goals. The Administrative Core will also review new areas for the development of programmatic or research initiatives in response to the needs of the community and facilitate the development of new minority investigators trained in health disparities research. These activities will create a center that can achieve goals that extend beyond its initial scientific and programmatic intention. The specific aims are 1) To provide the executive leadership and direction for the establishment of CEDREC as a comprehensive health disparities research center that integrates trans-disciplinary cutting-edge research, that provides strong mentorship for minority investigators, and that builds community capacity for research through partnerships;2) To expand CEDREC's presence within the partnering institutions and nationally and;3) To ensure that all initiatives conducted within CEDREC are in compliance with federal and institutional policies. The Administrative Core has assembled an impressive team of leaders to sit on the External Advisory Board that included leaders in public policy, health disparities research, minority health, and epidemiology such as Dr. Louis Sullivan, Dr. Hayden Bosworth, Dr. Giselle Corbie-Smith, Dr. Said Ibrahim, and Dr. Alfred Neugut. This team will work with Dr. Boutin-Foster to create a research enterprise that will advance the current understanding of health disparities and guide the development of effective interventions.